REDfly: The regulatory sequence resource for Drosophila and other insects

We have developed a unique resource, the REDfly (Regulatory Element Database for Fly) database of
transcriptional regulatory elements, to provide regulatory annotation for the genome of Drosophila and other
insects. The genomic sequences regulating gene expression—transcriptional cis-regulatory modules (CRMs,
e.g. “enhancers”) and transcription factor binding sites (TFBSs)—are not currently curated by any other major
database resources. This is a serious deficiency as CRMs play critical roles with respect to birth defects and
chronic diseases as well as normal development, phenotypic variation, and evolution. Knowledge of
experimentally validated CRMs and TFBSs is vital for many areas of research including interpretation and
validation of data developed by large-scale genomics projects, providing training data for machine-learning CRM-
discovery methods, genome annotation, modeling gene regulatory networks, studying the evolution of gene
regulation, and numerous aspects of the basic biology of transcriptional regulation. Knowledge of insect CRMs
is also an important step in developing biotechnology methods for control of insect disease vectors and for
eliminating pathogen transmission. REDfly includes experimentally verified CRMs and TFBSs along with their
DNA sequence, their associated genes, and the expression patterns they direct. It is the most detailed existing
platform for metazoan regulatory element annotation and is widely acknowledged as the premier resource in the
regulatory genomics arena. Only REDfly integrates all of the available insect cis-regulatory information from
multiple sources to provide a comprehensive collection of regulatory elements. The objectives of this proposal
are to keep REDfly up to date with the rapidly increasing numbers of CRMs and TFBSs being identified and to
update the REDfly site to maximize its utility to the research community. The focus is on: (1) Curation. REDfly
will continue to be kept up-to-date as new studies are published, and valuable data and metadata will be added
to existing records. (2) User interface. We will develop more sophisticated search, display, and download
capabilities to keep pace with the vastly increased amounts and types of data now contained in the database.
We will update software components that have become obsolete in the decade since their initial implementation.
(3) Data integration. We will increase integration of disparate data types and develop confidence scores for
annotations. (4) Workflow. We will increase our curation efficiency and ability through improved workflows. (5)
Ontology support. We will improve how we use biomedical ontologies through incorporating the latest ontology-
related software, including ontology browsers and SPARQL queries. The proposed activities are significant as
they will keep up-to-date a high-value resource for multiple research communities and increase REDfly’s utility
by adding needed new features and functions. REDfly has already demonstrated its essential and unique value
as an important platform for supporting hypothesis-driven empirical and computational research in multiple
research areas. It will have greatly increased impact through the updates and enhancements proposed here.

Public health relevance
The proposed research is relevant to public health because gene regulatory sequences have been linked to birth defects and both chronic and acute diseases. Knowledge of such sequences in insects is also critical in devising means for insect biocontrol and controlling insect-transmitted pathogens. The REDfly database is of proven value in contributing to our understanding of regulatory sequences by serving as a significant source of raw data for analysis, hypothesis generation, assessment and validation, and empirical research in a wide spectrum of important research areas spanning molecular and developmental biology, genetics, genomics, and bioinformatics.